Administrative and Engagement Core

ABSTRACT AEC
The Administrative and Engagement Core (AEC) of LISTOS
support
for Cancer Control seeks to
administrative, communication, and engagement activities across all Center functions.
The AEC will function as a cross-functional matrixed organization that will include staff and
capabilities distributed across INCan, INSP and UTHealth. Center cohesion, relational and
collaborative capacity, strong community engagement, and effective project management are all
important areas of focus for the AEC. The AEC will carry out its work through two functional
units: the Administrative Unit and the Communications & Engagement Unit. Through the
Administrative Unit, the AEC will provide coordination and project management support to all
Center activities. Through the Communications & Engagement Unit, the AEC will provide
effective internal and external communications support and support a dynamic engagement
strategy that includes supporting a Center External Advisory Panel, Implementation co-
Laboratories, and stakeholder engagement retreats.